Mucosal Repair in Gut Surgical Disorders

Abstract
Acute injury of the gut mucosa occurs commonly in patients with critical surgical
events such as trauma, thermal injury, shock, and massive surgical operations.
Because the exact mechanisms underlying gut mucosal injury/repair remain largely
unknown, effective therapies to preserve the epithelial integrity in patients with critical
surgical illness are limited, leading to acute massive hemorrhage, epithelial barrier
dysfunction, sepsis, and in some instances multiple organ dysfunction syndrome and
death. Recently, circular RNAs (circRNAs) have drawn increasing interest due to their
prevalence and range of potential biological functions by interacting with microRNAs
(miRNAs) and RNA-binding proteins (RBPs). In preliminary studies, our genome-wide
circRNA expression profiles reveal that ~300 circRNAs from total 9360, including Cdr1as
and circHIPK3, which were differentially expressed between injured mucosa induced by
septic stress vs uninjured mucosa from control mice. Ectopically expressed Cdr1as
inhibited intestinal epithelial repair after wounding, whereas circHIPK3 promoted
intestinal epithelial regeneration. Cdr1as and circHIPK3 were also found to interact with
several miRNAs such as miR-7 and miR-29b. Based on these exciting observations, we
advance a paradigm-shifting hypothesis that circRNAs Cdr1as and circHIPK3 play an
important role in intestinal mucosal repair by interacting with given miRNAs after acute
injury under critical surgical conditions. Three specific aims are proposed to test the
hypothesis: 1) To define the exact roles of Cdr1as and circHIPK3 in the regulation of
intestinal mucosal repair after acute injury induced by surgical stress; 2) To identify novel
target miRNAs of Cdr1as and circHIPK3 that are important for intestinal mucosal repair
after acute injury; and 3) To characterize the mechanism by which cellular abundances
of Cdr1as and circHIPK3 are regulated in response to critical surgical stress.
Completion of these experiments will make a significant conceptual advance by linking
the circRNA/miRNA interaction with gut mucosal repair after acute injury in patients with
critical surgical illnesses. The unique cellular stability and capacity of circRNAs to
interact with miRNAs and RBPs will also place circRNAs as promising targets or as
therapeutic vectors for developing new treatment to maintain gut epithelial integrity
or/and enhance mucosal repair after injury in surgical clinical setting.

Public health relevance
Project Narrative Patients with critical surgical events such as trauma, thermal injury, shock, sepsis, and massive surgical operations are commonly accompanied with an acute and massive gut mucosal injury and erosions. Since the exact mechanisms underlying mucosal injury/repair remain largely unknown, effective therapies to preserve the epithelial integrity in patients with critical surgical illnesses are limited, leading to acute massive hemorrhage, gut barrier dysfunction, and multiple organ dysfunction syndrome or death. Studies proposed this project will identify novel circRNAs in the control of gut mucosal repair after acute injury in critical surgical conditions and will create a fundamental basis for development of new therapies to protect the gut epithelium and enhance mucosal repair in patients with critical surgical illnesses.